Neurocognitive mechanisms of control over cognitive stability and flexibility

PROJECT SUMMARY/ABSTRACT
Humans have a uniquely developed ability to impose internal goals on how they interact with their environment.
Referred to as “cognitive control”, this capacity includes two core components: (1) the ability to focus attention on
currently goal-relevant stimulus features and responses (a “task set”) while ignoring task-irrelevant features (cognitive
stability); and (2) the ability to switch to a different task set when circumstances change (cognitive flexibility). Crucially,
to thrive in a dynamic environment, we need to continuously adapt our levels of cognitive stability and flexibility to suit
changing demands. E.g., when cooking a meal, needs for stability (e.g., a strong task-focus when slicing onion) and
flexibility (e.g., rapid shifting between recipe reading and stovetop monitoring) change frequently over time. The
strategic regulation of stability and flexibility is thus fundamental for success in everyday life, and is in fact severely
impaired in many clinical conditions. However, the underlying neurocognitive mechanisms are poorly understood. This is
due to the fact that, while there are large literatures on cognitive stability (in the shape of conflict-control studies) and
flexibility (in the shape of task-switching studies), these processes have been either investigated in isolation, conflated,
or not interrogated in terms of their dynamic adaptation. The present proposal seeks to overcome these barriers to
progress by combining a novel task protocol that assesses simultaneous and independent adaptive shifts in stability and
flexibility with computational modeling, functional magnetic resonance imaging (fMRI), and intracranial electro-
encephalography (iEEG). Our overall goal is to characterize the neurocognitive mechanisms of concurrent, strategic
control over cognitive stability and flexibility. We triangulate this goal via three aims: Aim 1 seeks to establish the first
computational model of concurrent stability and flexibility regulation by fitting and simulating behavioral data from
protocols with time-varying demands on stability and flexibility (Studies 1 and 2). Our working model consists of two
independent reinforcement learners making trial-by-trial predictions about forthcoming demands on stability (conflict-
likelihood) and flexibility (switch-likelihood), which in turn modulate distinct within-trial drift-diffusion model
parameters. Aim 2 employs the winning model to determine the neural mechanisms mediating these adjustments in
stability and flexibility. Building on a large prior literature, we use complementary fMRI (Study 3) and iEEG (Study 4)
approaches to test specific neuroanatomical hypotheses about the respective roles of the lateral prefrontal, posterior
parietal, and anterior cingulate cortex, as well as the basal ganglia, in supporting the proactive adaptation of stability
and flexibility to time-varying demands. Finally, Aim 3 will use fMRI to characterize the neural reinstatement of context-
appropriate stability and flexibility settings when they are applied reactively, i.e., in response to specific demand-
predicting stimuli (Study 5). Together, these complementary aims represent the first systematic investigation into the
computational and neural mechanisms underlying the concurrent regulation of cognitive stability and flexibility. This
innovative project will significantly advance our understanding of the neurocomputational bases of cognitive control,
and lay the groundwork for identifying potential failure modes of stability and flexibility regulation in clinical conditions.

Public health relevance
PROJECT NARRATIVE To survive and thrive in a dynamic environment, humans require the ability to focus on a task at hand while ignoring distraction (“cognitive stability”) as well as the ability to switch focus to a different task when goals or circumstances change (“cognitive flexibility”). The context-appropriate matching of cognitive stability and flexibility levels to different challenges in everyday life is severely impaired in many clinical conditions, but the underlying mechanisms of how the human brain dynamically regulates stability and flexibility are presently not well understood. This project combines a novel behavioral test of concurrent stability and flexibility adjustments with computational modeling of the underlying cognitive processes, and electrical and blood-flow measurements of brain activity, which together will allow us to reveal how the brain strategically adapts cognitive stability and flexibility to changing demands, and by inference, how these processes might be impaired in clinical populations.